Randomized controlled trial of an agricultural livelihood intervention to improve maternal and newborn health and nutrition in Kenya

PROJECT SUMMARY
Food insecurity is a critical driver of maternal and infant health and nutrition, including poor birth outcomes,
suboptimal breastfeeding, perinatal depression and stress, and poor child growth and development. Pregnant
women living with HIV are particularly vulnerable to food insecurity and face an excess risk of poor birth and
infant outcomes. In sub-Saharan Africa, where both food insecurity and HIV are highly prevalent and a third of
children under five are stunted, interventions to reduce food insecurity and malnutrition that are relevant for
both women with and without HIV are needed. In rural settings in this region, small-scale farming is the primary
source of livelihood, yet unpredictable rainfall, severe climate events, and limited irrigation hamper crop yields.
Agricultural livelihood interventions are a promising approach to raising income, bolstering food security, and
ultimately improving maternal and infant health and nutrition. Yet studies of agricultural interventions initiated in
pregnancy are lacking despite the fact that in utero exposures crucially predict pregnancy and infant outcomes.
The objectives of this proposal are to determine the effectiveness of an agricultural livelihood intervention on
improving maternal and infant health when initiated in early pregnancy, and to understand factors that
influence implementation of an agricultural intervention in the perinatal period, including the need for farming
support when pregnancy impacts women’s capacity to work in the fields. We propose a hybrid effectiveness-
implementation trial among 410 pregnant women enrolled at ≤20 weeks gestation, half living with HIV in
western Kenya. Women will be randomized 1:1 the intervention or routine care. Those randomized to the
intervention will receive guidance on obtaining farming support. Our central hypothesis is that by empowering
pregnant women with skills and tools for sustainable farming and perinatal nutrition, the intervention will lead to
improved maternal and infant health compared to control participants. We propose an HIV status neutral
approach to optimize the generalizability and potential reach of this intervention. Also, because HIV stigma and
poor health present additional barriers to empowerment and healthy behaviors, this intervention, which may
reduce these barriers, has the potential to alleviate infant health disparities associated with maternal HIV. We
propose the following aims: Aim 1: Determine the impact of the intervention on maternal, pregnancy and infant
health outcomes, among women living with and without HIV and their newborns. Aim 2: Determine the impact
of the intervention on empowerment, socioeconomic, and behavioral factors that may influence maternal and
infant health. Aim 3: Identify attitudes, norms, processes, and resources that influence implementation
outcomes and effectiveness of the intervention initiated in early pregnancy. This research will significantly
advance scientific understanding of whether, how, and under what circumstances an agricultural intervention
for pregnant women affects health.

Public health relevance
PROJECT NARRATIVE Food insecurity and HIV are highly prevalent in sub-Saharan Africa, and are important determinants of poor health outcomes among pregnant women and their infants. This randomized controlled trial among pregnant women living with and without HIV will examine the impact of an agricultural livelihood intervention on maternal and infant health, and will examine factors that influence implementation of the intervention during pregnancy and early postpartum. The project has the potential to demonstrate the role of sustainable agricultural and economic interventions in improving health and nutrition in the critical perinatal period in resource limited settings in sub-Saharan Africa.